Career Enhancement Program

CAREER ENHANCEMENT PROGRAM – PROJECT SUMMARY/ABSTRACT
Fundamental to advancing prevention, diagnosis, and treatment of hepatobiliary cancer (HBC) is the
engagement and focus of dedicated researchers. The central activities of the Career Enhancement Program
(CEP) in the NCI-supported Mayo Clinic SPORE in HBC meets this fundamental need by identifying, developing,
and monitoring the progress of the most promising investigators for translational research in liver and biliary
cancer. The CEP has demonstrated a strong track record of supporting applicants from two targeted groups: 1)
early-stage investigators and 2) mid-career investigators who previously have not engaged in HBC research.
The support includes financial ($100k/year) and extensive mentorship. This comprehensive program ultimately
will create an interdisciplinary network of researchers committed to the prevention, diagnosis, and treatment of
individuals with this disease. Awards are used to support studies of 1-year duration, with a requirement that
adequate need or progress is demonstrated for a second year of funding. In the ongoing funding period (Years
1-4), the CEP selected 7 investigators for 10 awards (3 awardees received a second year of funding). These
diverse investigators included women (2/7) and individuals from underrepresented ethnic groups (3/7). All remain
active translational investigators in the field of liver and biliary cancer. Five of the 7 awardees remain involved
with the HBC SPORE, while 2 awardees now are successful investigators in HBC research at other institutions.
A former CEP awardee is serving as a Co-Investigator of a full translational project in this renewal application.
To date, the CEP has resulted in significant successful scientific collaborations and additional funding, including
3 K-Awards and 1 R01 in HBC research, with others still pending. The success of the current CEP provides a
template for expanding and enriching this program. The CEP leadership will continue to widely advertise the
availability of CEP awards and use a rigorous and transparent process to review and select applicant candidates
based on career potential to initiate, obtain funding for, and conduct translational research addressing the
morbidity and/or mortality of HBC. Going forward, the CEP proposes to build on this success by 1) extending
recruitment to a broader pool of candidates and increasing the scope of activities by involving past awardees in
the 2) selection, 3) evaluation, and 4) mentoring of new candidates, which will nurture collaboration and provide
critical experience for future SPORE leadership. The expectation will continue to be that successful CEP
proposals will replace full SPORE projects or be eligible for other sources of extramural funding. The CEP is a
key component of the Mayo Clinic SPORE in HBC, as it provides a significant mechanism for increasing the
number and diversity of scientists and clinical investigators who are committed to translational HBC research.

Public health relevance
CAREER ENHANCEMENT PROGRAM (CEP) – PROJECT NARRATIVE This section is not applicable to the Career Enhancement Program.